RAPID QUANTITATION OF INHOMOGENEOUS EPR SPECTRA BY FAST CONVOLUTION ALGORITHM

Spectral simulation and optimization of simulated parameters to fit experimental data are very powerful tools for data analysis in EPR spectroscopy. Recently Halpern and coworkers developed a fast algorithm for quantitation of inhomogeneously broadened EPR spectra (Voigt lineshape). They approximated the Voigt profile by a sum of Lorentzian and Gaussian functions and used the Levenberg-Marquardt algorithm for multidimensional optimization. We describe an even more accurate and flexible approach to linewidth simulation based on a fast convolution algorithm (FCA). FCA was also applied for calculating the partial derivative matrix required for Levenberg-Marquardt optimization. All fitting parameters, including dispersion contribution, and Lorentzian and Gaussian linewidths are extracted directly. A fixed hyperfine and/or superhyperfine pattern may be included in the fitting procedure without broadening of a CTPO EPR spectrum at various oxygen concentrations and to study the penetration of a 1.13 GHz microwave field into a lossy dielectric sample.